Core Center for Clinical Research at Northwestern University

The overarching goal of the Northwestern University (NU) CCCR is to promote cutting-edge clinical research
aimed at prevention or control of rheumatic and musculoskeletal conditions and poor outcomes associated with
them. While we will provide broad support, we will particularly seek to drive this theme: prevention strategy and
intervention development through lifestyle, behavioral, medical, and rehabilitative solutions, built on a
foundation of person-centered assessment in daily life and community engagement. Our overall aims are to:
1) accelerate and enhance funded research, by increasing stakeholder engagement, efficiency, rigor,
collaboration, cost-effectiveness, productivity, and impact; 2) organize and catalyze all relevant research at
NU, applying a health equity lens, adding value, and moving it forward in a way that would otherwise not be
feasible; 3) promote new research within our mission areas, by expanding the Research Community working in
these areas and by expanding research fields within the mission. We will organize our resources into Cores but
function as an integrated unit. Methodologic Core aims are: 1) provide expertise in study design, methodology,
outcomes, and analysis planning; work with the Community Advisory Board and Resource Core to assist
design that incorporates personal and community perspectives; integrate, as needed, input on adaptive and
pragmatic study design, epidemiology, behavioral science, nutritional science, economic evaluation, policy
analysis, genomics, bioinformatics, and clinical informatics; 2) facilitate use of existing databases and
registries; 3) promote safe and responsible data management; 4) assist users in statistical analyses that
maximize the potential of study data; and 5) enhance the training environment. Resource Core, Community
Engaged Assessment and Intervention Science and Technology in Daily Life, aims are: 1) create and sustain
interaction between stakeholders and research teams through project stages: a) build pathways for
communityļacademic exchange to increase research value for improving health and equity by refining ideas
and planning in partnership; b) build capacity for community-engaged research; 2) help teams design research
that integrates personal and community perspectives; refine research questions, study design, assessment
plan, intervention comparators and intervention procedures, and assist with budget planning, with the
Methodologic Core; get stakeholder input on variables and outcomes and collaboratively develop assessment
plans that can include: social determinants of health; accelerometry to assess physical activity, sedentary
behavior, and sleep; mobile and sensor-based applications that identify behavioral markers; and wearable
biosensors to predict physiological and psychological states; 3) help teams operationalize their research and
create dissemination plans. Because our CCCR is centered on the goal to improve how persons feel and
function in daily life, focuses on community and personal experience, and builds upon the wearable and
portable technology revolution, we are positioned to have substantial impact on work within and beyond NU.

Public health relevance
In this application, we propose a Core Center for Clinical Research (CCCR) at Northwestern University to promote cutting-edge clinical research aimed at prevention or control of rheumatic and musculoskeletal conditions and poor outcomes associated with them. While we will provide broad support, we will particularly seek to drive this theme: prevention strategy and intervention development through lifestyle, behavioral, medical, and rehabilitative solutions, built on a foundation of person-centered assessment in daily life and community engagement. Because our CCCR is centered on the goal to improve how persons feel and function in their daily lives, focuses on community and personal experience, and builds upon the wearable and portable technology revolution, we are positioned to have substantial impact on work within and beyond our institution.